Characterization of two proteins that regulate vertebrate

The process by which a cell becomes polarized for directional migration is not well understood. The Wnt
signaling pathway is required for polarization and cellular motility during embryogenesis. This pathway is divided
into two branches termed canonical and non-canonical and the non-canonical pathway and is required during
vertebrate gastrulation and neural fold closure. Importantly, defects in non-canonical Wnt signaling are
implicated in birth defects disorders including spina bifida and also in human cancer metastasis. Despite the
compelling evidence that the Wnt pathway can mediate cytoskeletal changes for cell motility, it remains unclear
how this is accomplished along with the molecular factors and mechanisms involved in this process.
In our preliminary studies, we have determined that the Formin homology protein Dishevelled-associated
activator of morphogenesis (Daam1) links Dishevelled (Dvl) to the GTPase Rho to transduce non-canonical
Wnt signaling. In response to Wnt stimulation, Dvl binds Daam1 and mediates Rho activation. These steps
result in cytoskeletal reorganization required for cellular motility during gastrulation and neural fold closure in
the Xenopus embryo. However, it is not fully understood how Daam1 modifies the cytoskeleton and the identity
of the effector(s) downstream of Daam1 required for cytoskeletal reorganization remains unknown. We have
isolated two proteins as new uncharacterized binding partners for Daam1. Using co-immunoprecipitation (IP)
and GST-pulldown assays, we have verified that these proteins binds to Daam1 and defined the domains within
each protein required for binding. We observed that colocalized with Daam1 in culture cells and this localization
was sensitive to Wnt-stimulation. In Xenopus, gain-of-function and loss-of functions show both proteins further
regulates gastrulation in the non-canonical Wnt pathway with Daam1.
In building a model for the mechanism of action of these two proteins, we hypothesize that Wnt stimulation
regulates a Daam/protein complex formation, which activates these proteins which in turn mediates cytoskeletal
changes that are required for cell polarity and cell motility. We will pursue two specific aims in this R03 proposal
to test our hypothesis that these two proteins are key factors for Wnt-mediated cytoskeletal changes for
vertebrate gastrulation and neural tube closure utilizing Xenopus laevis, zebrafish and mammalian cell-culture
based systems. We hypothesize that these two proteins are essential mediators for non-canonical Wnt mediated
cytoskeletal regulation for cellular motility during vertebrate gastrulation and neural tube closure. Our
studies will test this hypothesis and provide insights into the Wnt-signaling network.

Public health relevance
Understanding the development of human pathologies including cancers and birth defect disorders requires that we identify the key signaling molecules and their signal transduction pathways that when deregulated will contribute to these pathologies. Our studies are focused on understanding the mechanisms by how two identified proteins regulate non-canonical Wnt signaling for gastrulation and neural tube closure. We propose that these studies can provide important new insights into the mechanisms regulating embryogenesis as well as providing insights into how deregulated Wnt signaling contributes to human pathologies including cancer formation and birth defect disorders.